CONTROLLED STUDY TO EVALUATE INTRAVENOUS AS-013 IN LIPID EMULSION

Peripheral arterial occlusive disease is a common cause of exercise-induced leg pain and ischemic ulceration in the elderly. There are few effective medical therapies for this disorder and frequently patients are poor surgical candidates for revascularization due to co-morbid disease or distal arterial occlusions. This phase 2 clinical study seeks to test the hypothesis that AS-013 (a lipid-encapsulated pro drug of prostacyclin, PGE1) may be effective in the treatment of ischemic ulceration due to peripheral arterial occlusive disease. This protocol is a multi-center randomized placebo prospective double-blind placebo-controlled study of 30 or 60 ug of AS-013 in the treatment of subjects with severe limb ischemia. The study drug or ploacebo will be given by vein once a day five days a week for eight sequential weeks. The total number of patients in the study is 510. The major endpoint is amputation rate at 180 days. Since last year, the Alpha Therapeutic Corporation-sponsored trial of AS-013 has enrolled 5 patients at Mayo Clinic Rochester. No patients are currently enrolled in the protocol, but all are alive in follow-up. The adverse events have all been noted by the appropriate IRB subcommittee. The plan is to continue this trial through at least the middle of 1999, with a target enrollment of 20 patients as originally planned.